Phase 0 Study to Evaluate the in vivo Characteristics of a Myeloperoxidase-Targeting PET Agent in Healthy Volunteers and Early AD Patients

Alzheimer’s disease (AD) is a devastating and progressive disease without a cure. Long thought to be a
consequence of AD, neuroinflammation is now recognized as a key early event in the development of
neurodegenerative diseases such as AD. Aberrant neuroinflammatory response activates immune cells that
can increase oxidative stress, and oxidative stress can directly damage neurons and axons, cause
demyelination, and break down the blood-brain barrier (BBB), and has been found in patients with early-stage
AD. However, current clinical imaging technologies do not specifically assess oxidative stress and cannot
distinguish between damaging and reparative inflammation. We have found that the enzyme myeloperoxidase
(MPO) is highly expressed by pro-inflammatory cells but not by reparative cells. MPO is a key mediator of
oxidative inflammation and has been found to be associated with AD. An increased number of MPO
immunoreactive cells have been found in the brains of AD patients, but not in the brains of normal patients.
We and others have found that an MRI agent targeting MPO (“MPO-Gd”) can detect neuroinflammation non-
invasively, from early to advanced stages, in stroke and multiple sclerosis, and can accurately track the
infiltration of early pro-inflammatory myeloid cells into the CNS non-invasively. However, MPO-Gd suffers from
the lower detection sensitivity of MRI techniques and cannot cross the blood-brain barrier (BBB). As such,
MPO-Gd is unable to detect the smaller amount of MPO activity found in AD. A PET imaging agent can
overcome these limitations. We have developed an activatable MPO-PET imaging agent (18F-EH301) that can
cross the BBB to enable imaging of MPO activity in AD. Under a funded SBIR, we have validated in rodents
that 18F-EH301 is highly stable without interfering metabolites, and 18F-EH301 PET imaging is specific to MPO
activity, crosses the blood-brain barrier, and can detect early neuroinflammation in the 5XFAD mouse model of
AD. Furthermore, an acute single-dose toxicology study in rats at 100X of the expected clinical dose revealed
no evidence of adverse effects, setting the stage for translation. The goal of this proposal is to perform a first-
in-human Phase 0 clinical study of 18F-EH301 to assess 18F-EH301’s in vivo characteristics, including the
ability to cross the human blood-brain barrier and validate its ability to be activated by human MPO in the AD
brain. Ultimately, we hope to provide a tool to image and track oxidative damaging neuroinflammation in AD
and other neurological disease. In this phase 1 SBIR application, we aim to 1) assemble and file an exploratory
investigational new drug (eIND) application and 2) conduct a first-in-human Phase 0 clinical study to study and
confirm the in vivo characteristics (pharmacokinetics, mechanism/pharmacodynamics, elimination, dosimetry,
metabolite, and biodistribution) in both healthy volunteers and early-stage AD patients. These studies will
provide us with valuable information not only on the behavior of 18F-EH301 in human subjects but also
establish feasibility and guide future clinical development of 18F-EH301 for AD patients.

Public health relevance
Alzheimer’s disease (AD) is a devastating and progressive disease without a cure. The enzyme myeloperoxidase (MPO) is a key mediator of oxidative stress and damaging inflammation associated with AD. This proposal aims to perform a first-in-human Phase 0 clinical study of the MPO-sensing PET agent 18F- EH301 in six healthy volunteers and six early-stage AD patients to assess 18F-EH301’s in vivo characteristics, including the ability to cross the human blood-brain barrier and validate its ability to be activated by human MPO in the human AD brain.